Improving Survival in Oral Cancer by Disruption of Tumor Progression

ABSTRACT/ PROJECT SUMMARY
Invasion is required for development and spread of head and neck cancer (HNC) but unfortunately there are
no strategies that effectively target invasion. This knowledge gap is due to limited progress in identifying and
understanding the underlying mechanisms that control invasion. While progress has been made in establishing
that epithelial to mesenchymal transition in HNC cells allows them to spread and become resistant to
treatment, critical mechanistic links are unknown. It is also unclear which tumors will spread and become
resistant to treatment. Given the continued poor survival of patients with HNC, this project will address the
following questions: 1) what are the mechanisms that encourage HNC to spread; 2) how is HNC protected
from radiation and who is at risk for developing resistance; and 3) how does HNC recur. This work will provide
the foundation for novel mechanism-based treatment strategies to improve the survival of patients with HNC.

Public health relevance
PROJECT NARRATIVE The proposed studies will develop a comprehensive understanding of the molecular pathways that control the spread and recurrence of head and neck cancer. This information will provide the foundation to appropriately select patients who will respond to existing treatments, and identify novel strategies to sensitize tumors to treatment. Ultimately this will improve survival of patients with head and neck cancer.